DOUBLE BLIND MULTICENTER CROSSOVER STUDY TO COMPARE THE SAFETY AND EFFICACY

The primary objective of this study is to demonstrate the efficacy of ULTRASE MT20 in the treatment of steatorrhea in CF patients with a history of pancreatic insufficiency. A second objective is to investigate the safety of ULTRASE MT20 and to measure the extent of protein malabsorption.